Discovery of Anticancer Agents of Diverse Natural Origin

OVERALL PROJECT SUMMARY
In this Program Project Grant (PPG) renewal application, the applicant group is representative of three primary
institutions, the Ohio State University (OSU), the University of Illinois at Chicago (UIC), and the University of
North Carolina at Greensboro (UNCG). The participants have combined their vast experience in the isolation,
structure elucidation, and biological evaluation of natural products, to the development of a consolidated,
integrated program for the discovery of novel anticancer agents of diverse origin for potential utilization as cancer
chemotherapeutic agents. Plant materials to be studied in Project 1 (OSU) have been collected in tropical
countries by established botanists, and also accessed from the Natural Products Repository of the National
Cancer Institute. Lichens and their fungal associates (Project 1), cyanobacteria (Project 2), and filamentous
fungi (Project 3; UNCG) will also be accessed. Organisms acquired will be extracted and evaluated in a diverse
battery of relevant mechanism-based, cell-based, and tumor-growth related assays currently operational at OSU
(Project 1), UIC (Core 1), Columbia University (through Project 3), and via other external collaborators (through
Core A at OSU). Dereplication of known active compounds will be accomplished at OSU, UIC, and UNCG using
computerized literature surveys and LC-MS coupled to bioassays. Bioassay-directed fractionation will be
employed in Projects 1-3 for the elucidation of the active principles. Lead development of active natural products
via medicinal chemistry and pharmacokinetics-related studies will be conducted at OSU (Project 1 and Core 2),
facilitated by the OSU Biostatistics group (Core A). Novel, active compounds thus discovered will be further
evaluated in our panel of in vitro and in vivo bioassays (Projects 1 and 3, Cores 1 and 2) and by some external
collaborators. Group decisions will be made regarding the further development of agents for potential use as
anticancer agents. The more advanced stages of biological and toxicological testing will be aided through
consultation with the Drug Discovery Institute of the OSU Comprehensive Cancer Center (through Core A). The
Consortium will work with the involvement of the NCI Program Director in the discovery process, and plans to
hold regular meetings of key scientific personnel (inclusive of our External and OSU Internal Scientific Advisory
Boards) to enhance communication and decision-making processes, to be organized by Core A. Excellent
facilities for the isolation, structure determination, chemical modification, synthesis, and in vitro and in vivo
biological evaluation, and overall project data management are available. The overarching goal of this PPG is to
identify lead compounds that ultimately have therapeutic value for the treatment of cancer.

Public health relevance
OVERALL PROJECT NARRATIVE Cancer is responsible for about one in every four deaths in the United States, and new treatments are urgently needed. It is the overall goal of the integrated studies in this renewal application to discover novel chemicals from selected tropical rainforest plants, as well as lichens, cyanobacteria and fungi, for development as cancer chemotherapeutic agents, particularly for tumors not cured by current treatment methods.